Circuit Interactions of Adult-Born Neurons

The anterior/ventral dentate gyrus is a key gateway for mood regulation and stress responsiveness in humans
and rodents. It contains a population of immature neurons throughout adulthood, providing a substrate for brain
plasticity responsive to diverse physiological and pathological experiences. An extensive rodent literature
establishes adult neurogenesis as a key factor for stress resilience, with independent lines of research
corroborating the idea that young dentate neurons contribute to stress responsiveness by modifying the
excitability of surrounding neurons. Yet the fundamental circuit mechanisms that underlie the interactions
between new and older dentate neurons and how these interactions are affected by agents that enhance
stress resilience are unclear. The goal of this project is to test a new mechanism to explain disparate ideas
about how adult-born neurons modulate the excitability of the ventral dentate gyrus. Combining
electrophysiological and pharmacological approaches along with anatomical labeling of synaptic circuits, we
will determine how neurogenesis plays a modulatory role in the ventral dentate circuit and how ketamine
affects the circuit interactions of adult-born neurons. Completion of the proposed experiments will reveal novel
mechanisms underlying the contribution of adult neurogenesis to dentate excitability and stress
responsiveness, potentially identifying new targets for treating stress-related mood disorders.

Public health relevance
This project will test how adult-born neurons affect excitability of a brain circuit that contributes to stress responsiveness. The results will provide foundational knowledge for understanding how endogenous mechanisms of stress resilience can be leveraged to counteract pathological consequences of chronic stress.